Induction and Specification of Hematopoietic Mesoderm

DESCRIPTION (provided by applicant): The molecular and cellular events underlying the formation and differentiation of mesoderm to blood and other derivatives are critically important for our understanding of mechanisms of normal development and of disease. Knowledge of hematopoietic development has benefitted enormously from methods that allow populations of cells at different stages of commitment to be isolated and characterized. Few surface markers are available for the isolation of very early mesodermal cell populations committed to the hematopoietic and vascular lineages. The earliest known cell surface marker of mesoderm is Flk1. Based on expression of Flk1 and Podocalyxin (Podxl) proteins, we succeeded in separating the primitive (embryonic, EryP) and definitive (adult) hematopoietic and vascular lineages in ES cell-derived embryoid bodies and demonstrated that the same subpopulations are present in mouse embryos. We developed transgenic mouse lines in which fluorescent proteins are expressed exclusively in EryP, permitting their tagging and tracking through gestation. Our ability to isolate and FACS puriy distinct, synchronized populations of EryP allowed us to define global gene expression profiles during six distinct stages of development, from progenitor (yolk sac) through circulating and fetal liver stages. Progenitor stage EryP expressed a set of genes involved in the canonical Wnt/β-catenin pathway, known to be essential for normal gastrulation and mesoderm formation. By analyzing mice doubly transgenic for reporters for Wnt/β-catenin (GFP) and EryP (CFP or cyan), we discovered that the canonical Wnt/β-catenin is active in most EryP progenitors and that there is a gradient of Wnt activity such that the highest progenitor activity is found in cells with the highest Wnt pathway activity. Interestingly, the caonical Wnt pathway is also active in immature definitive erythroblasts in the fetal liver. An understanding of the Wnt pathway during ontogeny is pertinent to human disease because it is reactivated during hematopoietic regeneration and is subverted in certain leukemias, although it does not appear to be essential for HSC function or lineage specific hematopoietic differentiation in the adult. In this proposal, we will test the hypotheses that: () the primitive and definitive hematopoietic and cardiovascular lineages arise from distinct subsets of mesodermal progenitors; (2) the Wnt/β-catenin pathway regulates erythroid development; and (3) the canonical Wnt signaling pathway primes the erythroid response to TGFβ1.

Public health relevance
PUBLIC HEALTH RELEVANCE: Characterization of mesodermal stem/progenitor cell populations will help govern the choice of starting cell populations for directed hematopoietic differentiation for therapeutic purposes. An understanding of red blood cell development at various stages of red cell ontogeny and comparisons between the primitive and definitive systems will be invaluable for the development of efficient methods for the production of transfusable red blood cells. It may also provide insights into the hematopoietic response to stresses such as irradiation and anemias of various etiologies. __SpecificAimsTextDelimiter__ Specific Aims Recent studies by our group and others are defining the events underlying the differentiation of mesoderm to blood cells. Our studies have focused on the primitive and the definitive hematopoietic lineages. Conditional induction of the homeodomain transcription factor Mixl1 in mouse embryonic stem (ES) cell-derived embryoid bodies (EBs) results in the acceleration of the mesodermal developmental program, with increased numbers of mesodermal, hemangioblastic, and hematopoietic progenitors. Microarray analysis identified Podocalyxin (Podxl), which encodes a cell surface protein related to CD34, as the gene most highly upregulated early after induction of Mixl1. Based on expression of Flk1 and Podxl protein, we succeeded in separating the primitive (embryonic) and definitive (adult) hematopoietic and the endothelial lineages in EBs. We will broaden the biological and translational impact of these observations by extending our studies to the mouse embryo, in which we identified the same subpopulations of cells, and to human pluripotent (ES and iPS) cells. Primitive erythroid cells (EryP) are the first cell type specified in the mammalian embryo. We developed transgenic mouse lines in which fluorescent proteins mark EryP and allowed us to enrich and isolate, for the first time, progenitors of this lineage. The ability to isolate and FACS purify distinct, synchronized populations of EryP made it possible to generate global gene expression profiles throughout six stages of their development, from progenitor (yolk sac) through circulation and fetal liver stages. We found that progenitor stage EryP express a collection of genes involved in the canonical Wnt/β-catenin pathway, which is essential for normal gastrulation and mesoderm formation in the embryo. By analyzing mice that are doubly transgenic for reporters for Wnt/β- catenin (GFP) and EryP (CFP or cyan), we discovered that Wnt signaling is active in most EryP progenitors. There is a gradient of Wnt activity such that the highest EryP progenitor activity is found in cells with the highest Wnt/β-catenin signaling. Canonical Wnt signaling is also active in immature definitive erythroblasts in fetal liver. An understanding of the Wnt pathway during ontogeny is pertinent to human disease because it is reactivated during hematopoietic regeneration in response to injury/stress and is subverted in some leukemias. Specific Aim 1. To test the hypothesis that the primitive and definitive hematopoietic and vascular lineages arise from distinct subsets of mesodermal progenitors. The goal is to identify mesodermal progenitors for primitive and definitive hematopoietic and vascular lineages in EBs from mouse and human pluripotent cells and in mouse embryos. Cell populations will be FACS-sorted on the basis of their expression of Flk1, Podxl, and other surface markers and their hematopoietic and vascular developmental determined using progenitor or differentiation assays and expression of cell surface and RNA markers. The developmental relationships of the various populations will be determined using reaggreggation assays. To define the sorted populations in greater detail, molecular fingerprints will be generated using customized real-time RT-PCR Fluidigm arrays. The results of these studies will help govern the choice of starting cell populations for directed differentiation to hematopoietic and cardiovascular lineages. Specific Aim 2. To test the hypothesis that the canonical Wnt/β-catenin signaling pathway regulates erythroid development. The goal is to evaluate the function of Wnt/β-catenin signaling in primitive and definitive erythropoiesis. We will use pharmacological and conditional loss-of-function (LOF) and gain-of- function (GOF) approaches in vitro and in vivo to evaluate the function of Wnt/β-catenin in developing erythroid cells during their ontogeny. These will include fetal liver extensively self-renewing (definitive) erythroblasts (ESREs) that can be cultured essentially indefinitely and then induced to terminally differentiate. Specific Aim 3: To test the hypothesis that canonical Wnt signaling primes the erythroid response to TGFβ1. Computational analysis of the intersection between genes expressed in EryP progenitors and regenerating hematopoietic cells identified genes encoding transforming growth factor beta receptors 1 and 2 as targets of both the Wnt pathway transcription factor TCF7L2/TCF4 and GATA2. EryP progenitors respond differentially to TGFβ1 in a dose-dependent manner. We will ask whether Wnt signaling functions sequentially or cooperatively with TGFβ1, using pharmacologic and genetic (LOF and GOF) approaches. Impact of the proposed studies: These studies will help to elucidate molecular mechanisms underlying the differentiation of the erythroid lineages and provide insights that may lead to improved and more efficient methods for the production of red blood cells from pluripotent or progenitor cells for clinical use.